Optimizing Protein Intake in Older Americans with Mobility Limitations

DESCRIPTION (provided by applicant): The recommended dietary allowance (RDA) for protein, set at 0.8 grams/kg/day for adult men and women, has engendered debate and many experts advocate protein intakes substantially above the RDA to help maintain muscle anabolism in older individuals. It is not known whether increasing protein intake in older Americans, whose current intake is below the RDA, increases skeletal muscle mass, muscle performance and physical function. Our first aim is to determine whether administration of 1.3 g7kg-17day-1 of protein, compared to the RDA (0.8 g7kg-17day-1), will result in greater improvements in lean body mass, maximal voluntary muscle strength and power, and self-reported and performance-based measures of physical function in older men. Our second aim is to determine whether the gains in lean body mass, maximal voluntary strength and self-reported and performance-based measures of physical function during testosterone administration are greater with 1.3 g protein than with the RDA in older men on a eucaloric diet. We will conduct a randomized, placebo- controlled, double blind, and trial using a 2 X 2 factorial design. Community dwelling, men, 65 years or older, who have self-reported mobility limitation, a daily protein intake of < 0.8 g7kg-17day-1 and no contraindications for testosterone therapy, will be randomly assigned to one of four groups: placebo injections plus protein 0.8 g7kg- 17day-1; placebo injections plus protein 1.3g7kg-17day-1; testosterone enanthate 125 mg weekly plus protein 0.8 g7kg-17day-1; testosterone enanthate 125 mg weekly plus 1.3 g protein7kg-17day-1. Treatment duration will be 6 months. The primary outcome is change in lean body mass from baseline to 6 months, measured by dual energy X-ray absorptiometry. Secondary outcomes include change in maximal voluntary strength in leg and chest press exercises, leg power, self-reported (physical function domain of SF-36) and performance-based measures of physical function (6-min walking distance and speed, stair climbing power, and load carrying), fatigue, wellbeing, and affectivity balance. Safety measures include estimated GFR, urinary calcium excretion, hematocrit, PSA, and prostate examination. Several strategies - packaged meals, portion control, frequent reinforcements, and compliance checks by using food compliance checklists - will be used to enhance compliance with dietary prescription. Careful subject selection, incorporation of the attributes of good trial design such as randomization, stratification, and blinding, an appropriate sample size based on consideration of effect size and power, attentive safety monitoring, and a multidisciplinary team should maximize the chances of successful attainment of the proposed aims, which have important public health and policy implications.

Public health relevance
PUBLIC HEALTH RELEVANCE: The recommended dietary allowance (RDA) for protein has invited a great deal of controversy. Many experts advocate higher levels of protein intake for older individuals than the current RDA. We will determine whether higher protein intakes alone are safe and more effective than the RDA in improving lean body mass and physical function and whether this higher protein intake augments the anabolic response to function promoting anabolic therapy in older persons with mobility limitations. This issue has enormous public health and policy implications for older Americans. Narrative The recommended dietary allowance (RDA) for protein has invited a great deal of controversy. Many experts advocate higher levels of protein intake for older individuals than the current RDA. We will determine whether higher protein intakes alone are safe and more effective than the RDA in improving lean body mass and physical function and whether this higher protein intake augments the anabolic response to function promoting anabolic therapy in older persons with mobility limitations. This issue has enormous public health and policy implications for older Americans. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS The recommended dietary allowance (RDA) for protein has been set at 0.8 grams/kg/day; this allowance is intended to meet the needs of essentially the entire adult population - men and women, young and old (1). However, the protein requirements in older individuals remain poorly validated and have engendered vigorous debate (2-6). Many experts advocate dietary protein intakes substantially above the current RDA to help maintain muscle anabolism in older individuals; these scientists cite epidemiological studies and intervention trials which suggest that protein intakes above the current RDA (0.8 g ¿ kg-1 ¿ day-1) for older adults have beneficial anabolic effects on the skeletal muscle (2, 3, 7-17). Other experts have expressed strong dissenting views and support the current protein RDA (4, 5). There is some evidence that the anabolic response of the skeletal muscle to dietary protein is attenuated in older individuals (18-20), and that the amount of protein needed to achieve anabolism may be greater in older individuals than in young individuals (7, 14, 17, 21-23). In short-term studies, protein intakes of up to 1.6 to 1.8 g ¿ kg-1 ¿ day-1 have been shown to promote nitrogen retention (24). Many studies used urinary nitrogen balance as a surrogate measure of muscle anabolism and did not control total energy intake so that the effects of changes in energy intake could not be discerned from those of changes in protein intake alone. Furthermore, intervention trials using protein intakes higher than the RDA have failed to demonstrate improvements in lean body mass or measures of physical function (19, 25-29, 254). Hence, the efficacy of protein intakes in excess of the RDA in improving skeletal muscle mass, muscle performance and physical function has not been demonstrated in older individuals and is an issue of enormous public health and policy implications. An exhaustive survey of nutrient intakes in approximately 50,000 Americans residing in 48 states by the US Department of Agriculture revealed that about a third of older Americans do not ingest the RDA for protein (30); more recent surveys have confirmed these findings (31). Low protein intake has been implicated as a remediable contributor to the multifactorial pathophysiology of sarcopenia, the aging-associated loss of muscle mass and function, which has been recognized by the Centers for Disease Control and National Institute on Aging as one of the major health risks facing older Americans (2, 7, 9, 11, 13-15). However, we do not know whether increasing protein intake in older Americans, whose protein intake is below the RDA, increases skeletal muscle mass, muscle performance and physical function. Therefore, the primary objective of this investigation is to determine whether increasing protein intake in older Americans with daily protein intake less than the RDA to 1.3 g ¿ kg-1 ¿ day-1 will result in greater gains in lean body mass, muscle performance and physical function than protein intake that equals the RDA (0.8 g ¿ kg-1 ¿ day-1). Nitrogen balance studies in athletes have suggested that protein intake substantially greater than the RDA may be required to maintain nitrogen balance in individuals undergoing resistance exercise training and that even higher protein intake may be needed to achieve positive nitrogen balance and optimize adaptations to exercise training in these athletes (8, 16, 32-35). Remarkably, however, the studies in older individuals have failed to demonstrate unequivocal improvements in lean body mass or physical function in older individuals fed higher amounts of protein in excess of the RDA (24-26, 36, 37). The evidence is more persuasive, but not conclusive, that increased protein intake in the setting of an anabolic stimulus, such as resistance exercise training or testosterone therapy, may be associated with gains in lean body mass and muscle strength (23, 24, 38). A large number of promyogenic function promoting anabolic therapies such as testosterone, selective androgen receptor modulators (SARMs), myostatin antagonists, and growth hormone and its secretagogues, are being investigated for their efficacy to prevent and treat aging-associated loss of skeletal muscle mass and physical function; the protein requirements for achieving optimal anabolic response to administration of promyogenic function promoting therapies are unknown. Therefore, our second objective is to determine whether a higher level of protein intake - in excess of the RDA - is needed in older individuals to optimize anabolic response to a promyogenic function promoting anabolic therapy. Specific Aim 1 To determine whether administration of 1.3 g ¿ kg-1 ¿ day-1 of protein results in greater improvements than the RDA (0.8 g ¿ kg-1 ¿ day-1) in lean body mass, maximal voluntary muscle strength and power, and self- reported and performance-based measures of physical function in older men whose daily protein intake is less than the RDA and in whom energy intake is maintained constant Hypothesis 1 In older individuals whose daily protein intake is less than the RDA, increasing dietary protein intake to 1.3 g ¿ kg-1 ¿ day-1 without changing the total daily energy intake, will not result in significant improvements lean body mass, maximal voluntary strength, and self-reported as well as performance-based measures of physical function. Specific Aim 2 To determine whether the gains in lean body mass, maximal voluntary strength, and self-reported and performance-based measures of physical function during testosterone administration are greater with 1.3 g protein than the RDA in older men whose baseline daily protein intake is less than the RDA and in whom energy intake has been standardized Hypothesis 2 The RDA of 0.8 g ¿ kg-1 ¿ day-1 protein intake is insufficient to attain optimal anabolic response to administration of a promyogenic function promoting therapy, such as testosterone. In individuals whose daily protein intake is less than the RDA, increasing dietary protein intake to 1.3 g ¿ kg-1 ¿ day-1 without changing the total daily energy intake, will augment anabolic response to testosterone therapy and will be associated with greater gains in lean body mass, maximal voluntary strength, and physical function than the RDA. Approach We will conduct a randomized, placebo-controlled, parallel group, double blind, clinical trial using a 2 X 2 factorial design, which will allow us to investigate the separate and combined effects of dietary protein intake and testosterone administration. The participants will be community dwelling, older men, 65 years of age or older, who have self-reported mobility limitation, whose daily protein intake is < 0.8 g ¿ kg-1 ¿ day-1 and who have no contraindications for testosterone therapy. The subjects will be randomly assigned to one of four treatment groups using stratification for age and diabetes status: placebo injections plus protein 0.8 g ¿ kg-1 ¿ day-1; placebo injections plus protein 1.3 g ¿ kg-1 ¿ day-1; testosterone enanthate 125 mg IM weekly plus protein 0.8 g ¿ kg-1 ¿ day-1; testosterone enanthate 125 mg IM weekly plus 1.3 g protein ¿ kg-1 ¿ day-1. Energy intake will be maintained constant. Treatment duration is 6 months. Our primary outcome is change in lean body mass from baseline to 6 months by using dual energy X-ray absorptiometry (DXA). Our secondary outcomes are change in maximal voluntary strength in the leg press and chest press exercises, leg power, self-reported (physical function domain of SF-36) and performance-based measures of physical function (6-minute walking distance and speed, stair climbing power and speed, and load carrying). Safety measures include estimated GFR, urinary calcium excretion, hemoglobin and hematocrit, PSA, and digital prostate examination. The effects of protein intake on fatigue, affect, and sense of well being will be assessed by validated instruments.